Cellular and molecular mechanisms regulating synovial joint development

Project Summary and Abstract
Synovial joints are essential for body motion and quality of life. Their synovial cavity and lubricant-rich fluid
permit unhindered joint motion and function and provide tissue protection and nourishment. While these
aspects of synovial joint biology are well understood, little is known about how the cavity and its fluid actually
develop during embryogenesis. At early fetal stages, the limb skeletal primordia are composed of continuous
cartilaginous structures without joints. Joint development starts with appearance of an “interzone”, a tissue
made of mesenchymal cells expressing the growth and differentiation factor 5 gene (Gdf5). We previously
showed that Gdf5+ cell progenies produce most joint tissues over time and the synovial cavity forms in the
middle of the interzone. Because the interzone cells are initially attached to each other, the cavitation process
must involve their physical separation along the prospective articular line to facilitate the creation of a fluid-filled
cavity. Previous studies indicated that interzone cells produce hyaluronan (HA) around the cavitation time, and
this is accompanied by accumulation of a HA-rich matrix in local tissues. HA is a major component of
extracellular matrix and synovial fluid and plays important roles in tissue homeostasis. In my preliminary
studies, I found that just before cavitation onset, interzone cells in mouse embryo limbs express hyaluronan
synthase 2 (HAS2, ‘the HA synthesizer’) and transmembrane protein 2 (TMEM2), a cell surface hyaluronidase
that specifically cleaves high molecular weight HA into intermediate and biologically-active fragments. I also
discovered that, morphologically, cavitation initiates with formation of microlumens along the prospective
articular line and is completed soon afterwards when the pockets coalesce to generate a single one synovial
cavity. This process is extremely rapid in the developing knee but is slower in digits. These and other novel
data lead to my central hypothesis that joint cavitation is brought about by convergence of diverse but
coordinated biological processes. Accordingly, Aim 1 is to determine the role of HAS2 and TMEM2 in joint
cavitation using genetically modified mouse models. I will conditionally delete Has2 and/or Tmem2 in interzone
cells (using Gdf5Cre mice) and subject resulting mutant embryos to detailed analysis. Aim 2 is to determine
cellular and molecular mechanisms of cavitation. I will investigate downstream signaling pathways in response
to changes in HA sizes and resulting interactions with cell surface CD44 receptor, regulating HA metabolism in
synovial joint development and long-term maintenance. The project will provide novel insights into mechanisms
underlying joint development and cavitation. In line with the K01 mechanism, the project will allow me to
acquire new expertise in skeletal developmental and molecular biology and to integrate it with my previous
training in bioengineering. This unique combination of expertise in two distinct but interrelated fields will allow
me to establish an independent career distinct from my mentors and create novel therapeutic tools to repair
and regenerate cartilage for the treatment of joint conditions such as osteoarthritis (OA).

Public health relevance
Project Narrative The objective of this project is to investigate cellular and molecular mechanisms that regulate synovial joint development. In particular, this study provides novel insights into mechanisms underlying joint progenitor cell function and cavitation. Understanding dynamics of hyaluronic acid (HA) metabolism regulating joint formation during embryonic development will provide novel insights into creation of superior therapeutic tools to treat degenerative joint conditions such as osteoarthritis (OA) in a clinically-relevant manner (i.e., HA injection).